Ovarian impacts of extreme heat and co-exposure to climate change-induced harmful algal bloom toxins (Admin Supplement to R01ES032144)

PROJECT SUMMARY
Climate change is increasingly recognized as a global threat to human health. One major consequence of climate
change is the more frequent and intense extreme heat events. Previous research reveals adverse effects of
exposure to extreme heat or hot weathers on women’s pregnancy, such as preterm/still birth and low birth weight;
however, little is known regarding the impacts of extreme heat on female fertility which affects up to 10-15%
women worldwide including the US. Demographic studies revealed that women experiencing high temperatures
two weeks before the sexual intercourse had reduced conceptions and a large decline in birth rates 8-10 months
later, and there were negative associations between exposure to higher ambient temperatures and less antral
follicle counts in reproductive aged women. These human data highlight that extreme heat likely affects ovarian
follicle development and oocyte maturation before the conception. Previous research using large farm animals
has long documented the deleterious effects of heat stress on oocyte quality. However, it is unknown whether
the compromised oocyte quality is caused by the direct impact of heat stress on oocytes, the indirect effect on
the entire follicles, or both, as well as the molecular mechanisms involved. The global temperature rise is also a
major driver of other climate change and environmental crises, such as climate change-related harmful algal
blooms (HABs) which are the excessive growth of cyanobacteria, often refers to as the ‘blue-green algae’.
Humans are exposed to toxins released from HABs via contaminated drinking water, food, and recreational
activities. In our parent R01 project (ES032144), we have demonstrated that microcystin-LR (MC-LR), the most
common HAB toxin, interfered with gonadotropin-dependent follicle maturation and related hormone secretion,
and ovulation. So far, most studies focus on a single type of climate change stressor, but the reproductive impact
of multiple crises in the real world such as co-exposure to extreme heat and HAB toxins is unknown. Our
preliminary data revealed that exposure to extreme heat in vitro activated heat shock response genes in mouse
follicular cells and/or oocytes, and it also inhibited follicle growth, hormone secretion, ovulation, and oocyte
meiosis in a temperature-dependent manner. With these findings, we hypothesize that extreme heat activates
heat shock and other cellular stress responses to interfere with folliculogenesis and/or oogenesis, and
co-exposure to extreme heat exacerbates HAB toxin-induced ovarian toxicities, which will be tested in two
Specific Aims using our established 3D encapsulated in vitro follicle growth (eIVFG) system. In Aim 1, we will
identify the mechanisms by which extreme heat disrupts folliculogenesis and/or oogenesis. In Aim 2, we will
determine the ovarian impacts of co-exposure to extreme heat and HAB toxins. Giving the concurrently increasing
trends of extreme heat and HABs, which is only projected to escalate in the coming decades, elucidating ovarian
disrupting effects of extreme heat and its co-exposure to HAB toxins will enable us to speed up the development
of prevention, mitigation, and remediation methods to protect female reproductive health and fertility.

Public health relevance
PROJECT NARRATIVE Climate change and its major consequence of rising global temperatures or global warming are increasingly recognized as a global health threat to humans, including female reproduction. The goal of this NIH supplement application is to investigate the ovarian disrupting effects of exposure to extreme heat as well as the effects of co-exposure to climate change-related extreme heat and emerging harmful algal bloom (HAB) toxins.